GENETIC ANALYSIS OF VERTEBRATE RETINA DEVELOPMENT

DESCRIPTION (Adapted from applicant's abstract): The long-term objective of the proposed research is to uncover genetic and molecular mechanisms of cell differentiation in the vertebrate retina. Recessive mutations affecting the development of the eye in zebrafish (Danio rerio) have been recovered from a chemical mutagenesis screen, and the applicant proposes to further characterize these mutant lines. The first aim is to examine the mutant eyes by histological and immunological analysis, and to select a few lines for further analysis. The second aim is to define the nature of the mutated genes by genetic mosaic analysis (transplanting cells from mutant into wildtype embryos) and by complementation analysis (searching for additional alleles of the mutated genes by genetic methods).